Modulating 3D Cellular Connectivity Via Spatially-Controlled Programmable Bonding

Project Summary
The hierarchical arrangement of cells within tissue plays an important role in determining function. As part of this
hierarchical arrangement, different cell types are spatially arranged in contact with one another in a way that
transmits important signaling cues that direct a multitude of different functional and dysfunctional cellular
responses, such as altered gene expression, migration, metabolite sharing, and survival. A greater
understanding of how cell arrangement impacts these behaviors would have important repercussions for a host
of developmental processes that include stem cell differentiation, cancer metastasis, scar tissue formation,
immunology, and angiogenesis. While the importance of spatially-regulated hierarchical cell arrangements is
well established, methods for reproducing this complexity with high precision remain limited. Conventionally,
model organisms have informed much of what is understood about these processes, but often do not allow
constant direct observation and control. Rapidly evolving 3D printing methods have greatly enhanced our ability
to place cells on substrates with libraries of different materials. However, these technologies do not allow one to
precisely place individual cells in contact with each other in order to understand how different arrangements drive
biological processes in highly heterogenous cell populations. Likewise, techniques that facilitate cell-cell contact
placement do not readily enable 3D control with multiple different cell types. This proposal seeks to establish the
feasibility of technology that would address this biomedical technological need. Specifically, it evaluates the use
of oligonucleotide (short DNA sequences) to precisely control cell placement in an interchangeable and on-the-
fly fashion. Aim 1 of this proposal seeks to establish new methods and design rules for dynamically and
sequentially adding multiple different cells to a surface with high fidelity and spatial control. Aim 2 seeks to
develop a new approach to building spatially controlled 3D cell assemblies using programmable DNA.
Completion of this proposal will establish feasibility of this technology for future applications in biomedical
studies.

Public health relevance
Project Narrative Spatially-defined cell-cell communication plays a critical role in numerous disease and developmental processes that include osteoarthritic degeneration, cancer metastasis, and organ regeneration. This project seeks to demonstrate proof-of-concept for technology that allows one to systematically place cells on substrates to create complex 3D assemblies with precise control over individual cellular interactions. The technology generated within this proposal will open new avenues for studying degenerative diseases, engineering artificial tissues, and understanding developmental processes.